Understanding and targeting unique vulnerabilities governing G1/S transition and replication stress in small cell lung cancer

Project Summary/Abstract:
Small cell lung cancer (SCLC) is a recalcitrant cancer that will kill more than 30,000 Americans this year.
Annual incidence is nearly equal to mortality rates, and even patients with earlier stage disease infrequently
live for two years beyond their diagnosis. There is currently a desperate need for novel therapies for SCLC.
Any condition leading to elevated levels of DNA damage will result in replication stress which in turn is a
source of genomic instability and increased vulnerability to specific agents including ATR inhibitors and DNA
damaging agents. SCLC is characterized by high levels of replication stress (RS) although the exact
mechanism causing the increased RS in SCLC is poorly understood. Interestingly, I have demonstrated that
low LMNA (a nuclear structural protein) is highly correlated with increased RS, and that SCLC cells have very
low levels of LMNA. I have demonstrated that low LMNA leads to increased chromatin accessibility and
increased R-loops (RNA DNA hybrids) due to promoter proximal pausing of RNA Pol-II. R-loops are highly
associated with RS, and replication fork collisions with R-loops can even cause DNA damage. The first aim of
this grant is to fundamentally understand whether low LMNA causes increased RS in SCLC, and if so to
determine if the mechanism R-loop dependent. Secondarily, during the R00 portion of this work, I plan to target
R-loops and LMNA utilizing R-loops stabilizing agents and LMNA inhibitors to augment ATR/DNA damage
based therapeutic regiments we have demonstrated have greater efficacy in SCLC patients with increased RS.
SCLC cancers are characterized as having strong neuroendocrine (NE) differentiation, and a high prevalence
(~80%) of RB (tumor suppressor which suppresses G1/S transition) mutation in patient tumors. I have
demonstrated that SCLC cells compared to other cancer types are highly sensitive to loss of G1/S transition
facilitating targets (G1ST) including CDK2, E2F, Cyclin E and SKP2. This is unsurprising as many of these
targets have been found to be synthetic lethal with RB mutation. However, I have demonstrated that RB
proficient SCLC cells (no RB1/2 mutation or copy number loss) are still more sensitive to loss of G1ST, and
this increased dependency is strongly correlated with NE differentiation. My second aim is to determine
whether the increased dependence of SCLC on these G1ST is caused by RB mutation, NE differentiation, or a
combination of both factors, and to determine the mechanistic underpinning of this interaction. During the R00
portion of this work I will target G1ST to augment standard of care regimens in SCLC.
This work will provide deliverables as follows: 1) determine the mechanistic underpinning of increased RS in
SCLC 2) a novel therapeutic approach targeting RS, LMNA and R-loops in SCLC 3) determine mechanisms
behind increased SCLC on G1ST 4) a novel therapeutic approach targeting G1ST in SCLC.

Public health relevance
Project Narrative This proposal aims to mechanistically define novel vulnerabilities of small cell lung cancer (SCLC) during the K99 phase and to pre-clinically validate targeting these vulnerabilities during the R00 phase. Aim 1 of this work is to further understand the mechanistic underpinnings (low LMNA, increased R-loops) of the increased replication stress observed in SCLC (K99) and to target these factors to augment ATR inhibitor based therapeutic regimens (R00). Aim 2 is to determine why SCLC cells display increased dependence on G1/S transition facilitating targets (K99) and to augment standard of care regimens by targeting these factors (R00).